NME Mouse Core

Summary
Core B NME Mouse Core
Our published studies suggest that mice with more physiological exposure to natural mouse microbes have
immune systems that are a better match for the immune system in humans: In contrast to typical “clean”
laboratory mice (which are maintained in barrier facilities to avoid pathogen exposure) these “dirty” mice – also
called normal microbial experience (NME) mice – may therefore be more useful to model the characteristics
and function of the human immune system, including the maintenance and breakdown of immune tolerance.
The goal of this NME Mouse Core is to reliably and cost-effectively produce NME animals that can be used by
the Projects in this P01, including careful quality control of these animals to make sure that they are suitably
well defined for interpretable studies.